A pilot trial of an intervention to support initial type 2 diabetes selfmanagement among younger adults with children.

ABSTRACT
More adults are being diagnosed with type 2 diabetes (T2D) at younger ages and are at increased risk of
developing micro- and macrovascular complications occurring earlier in their life courses. The year following
T2D diagnosis presents a critical window in which effective behavior change interventions that lead to
improved early glycemic outcomes can influence long-term diabetes-related health (i.e., the “Legacy Effect”).
Fewer than half of younger adults (ages 21-44 years at diagnosis) achieve the recommended HbA1c target of
<7% during the year following diagnosis, compared to 62% of individuals diagnosed later. These age-related
differences in achieving early glycemic targets highlight the need for novel approaches to support
behavior changes among newly diagnosed younger adults. Current T2D self-management programs are
not tailored to address the distinct life demands of many younger adults, particularly the responsibility of
parenting young children. Our prior qualitative work has noted that while the time and priority given to
children’s needs may limit parents’ opportunities for T2D self-management, the desire to remain healthy, model
healthy behaviors, and reduce children’s T2D risk may motivate healthy behavior changes. Building on this, we
hypothesize that a tailored, virtually delivered, family-inclusive T2D self-management support program whose
content and design are informed by common barriers and facilitators experienced by younger adults with
children will lead to greater behavior changes than standard care. We used preliminary data, clinical expertise,
the Capability-Opportunity-Motivation-Behavior (COM-B) behavior change framework, and Family Systems
Theory to develop our program, STRIDE (SupporTing paRents with DiabEtes). STRIDE includes 3 virtual
group sessions (1. Prioritizing Self-Care, 2. Eating Well Together, and 3. Getting Active as a Family) and
tailored interactive text messages. In the proposed small R01, we will conduct a randomized, pilot trial of
STRIDE vs. a waitlist control in adults ages 21-44 years (n=75 participants per arm) with newly diagnosed T2D
who are caregivers to at least one child ages 5-14 years. Individuals allocated to the waitlist arm will be invited
to participate in STRIDE after the intervention period is complete. We will assess STRIDE’s preliminary
efficacy (Aim 1), specifically its impact on participants’ diabetes distress and self-efficacy, known mediators of
improved glycemic control. Secondary outcomes include between-arm differences in HbA1c, medication
initiation and adherence, and engagement in T2D self-care. We will use STRIDE session observations, post-
intervention participant surveys, interviews with a subset of intervention participants, and interviews with the
health educators and dieticians delivering STRIDE to examine the program’s implementation and explore
factors that may mediate impact (Aim 2). The results of the proposed research will inform behavior change
support strategies for newly diagnosed younger adults and lay the groundwork for a future, larger-scale,
effectiveness trial to evaluate a refined and optimized version of STRIDE in real-world clinical care.

Public health relevance
PROJECT NARRATIVE Adults diagnosed with type 2 diabetes at a younger age (defined here as age 21-44 years) have higher rates of complications and are less likely to achieve recommended disease management targets than people diagnosed later in life, with differences in achieving glycemic targets present within a year of diagnosis. Current type 2 diabetes self-management support programs are not tailored to address the distinct life demands experienced by many younger adults, specifically, the barriers and facilitators related to the parenting of young children. In this small R01, we will pilot a novel, tailored, family-inclusive intervention (STRIDE [SupporTing paRents with DiabEtes]) developed to address potential challenges to type 2 diabetes self-management experienced by younger adults who are caregivers to young children (ages 5-14 years) to assess its impact on participants’ diabetes distress, diabetes self-efficacy, engagement in diabetes self-management activities, and hemoglobin A1c values.